Community Mobilization for Improved Clean Cookstove Uptake, Household Air Pollution Reduction, and Hypertension Prevention

PROJECT SUMMARY
Annually 4.3 million premature deaths are attributable to household air population (HAP) from solid fuels used
for cooking. In Nigeria, 90 million households cook with solid fuels. The use of clean (i.e. high-efficiency and low
emission) cookstoves can reduce HAP and improve health outcomes. In our RCT of 271 women in Nigeria, use
of “clean fuel-clean-stove” (CF-CS) vs. kerosene-based stoves led to significant blood pressure (BP) reduction
and an 80% adoption rate. However, its widespread adoption is sub-optimal in Africa because these countries
often lack expertise needed to coordinate system changes to implement evidence-based practices without
assistance. Community mobilization (CM) strategy may overcome this barrier because it builds community
readiness and support for normative changes. Thus, CM may enhance the demand for CF-CS use by modifying
community barriers to its adoption. In collaboration with the Lagos State ministry of health (MoH), we will develop
a context-specific CM strategy, and evaluate its effects on adoption and sustainability of affordable bioethanol-
based CF-CS use in Lagos, Nigeria. The CM strategy includes: (1) Community advisory board (of local
organizations, government officials, and residents), that will provide leadership support and buy-in for adoption
of CF-CS use; (2) Trained community health extension workers [from the MoH], who will facilitate proper
household use of CF-CS through community action teams (CATs); and (3) Community dialogues that are
focused on shared concerns regarding CF-CS use in households. Using a focused) implementation research
framework, the EPIS (Exploration, Preparation, Implementation and Sustainment) model, in a type-2 hybrid
design, we will conduct this study in 3 phases: 1) A pre-implementation phase that will explore barriers and
facilitators of CF-CS use, and develop a CM strategy for CF-CS use; 2) An Implementation phase to compare in
a cluster RCT the effect of CM vs. a self-directed condition (i.e. receipt of information on CF-CS without CM) on
adoption of CF-CS use; and systolic BP reduction; 3) A post-implementation phase that will compare the effect
of CM strategy vs. self-directed condition on sustainability of the CF-CS use in periurban communities in Lagos.
AIM 1: To conduct a needs assessment on community readiness for the adoption of CF-CS use in periurban
communities in Lagos; develop and pilot test a culturally-tailored CM strategy. AIM 2 will compare in a cluster
RCT of 32 periurban communities, the effect of CM vs. self-directed condition on adoption of CF-CS use in 640
households; AIM 3 will compare the effect of CM vs. self-directed condition on systolic BP reduction; and AIM 4
will evaluate the sustainability of CF-CS use one year after completion of the trial. The primary outcome is
adoption of CF-CS use defined as utilization of CF-CS for more than 50% of cooking activities in the household,
measured with iButtons stove usage monitors. The secondary outcomes are mean change in systolic BP from
baseline to 12 months; and sustainability of CF-CS use [maintenance of adoption at 24 months], one year after
the trial.

Public health relevance
PROJECT NARRATIVE Using a focused implementation research framework, the EPIS (Exploration, Preparation, Implementation and Sustainment) model in a type-2 hybrid design, we will conduct this study in 3 phases: 1) A pre-implementation phase that will use the Exploration and Preparation domains of EPIS to: a) explore barriers and facilitators of CF-CS use, and b) develop a culturally-tailored CM strategy for CF-CS use; 2) An Implementation phase that will use the Implementation domain of EPIS to compare in a cluster RCT of 32 periurban communities (640 households), the effect of CM vs. a self-directed condition (i.e. receipt of information on CF-CS use without CM) on adoption of CF-CS use; and systolic BP reduction; 3) A post-implementation phase that will use the Sustainment domain of EPIS to evaluate the effect of CM strategy vs. self-directed condition on sustainability of the CF-CS use in 640 households across the randomly assigned 32 periurban communities in Nigeria. University of Ibadan working with the MOH will oversee research coordination in Nigeria. The